CORE--BIOSTATISTICS

The biostatistics component will provide the capabilities for making comparisons of results within each of the projects and provide techniques for comparing results among projects. In addition it will provide a database system for managing the many pieces of information that will be acquired about the sample donors and data which will be generated from the multi-end point sample analyses.